Boron-Rich Cluster Materials for Vibrational- and Mass Spectral-Based Bioimaging of Reactive Oxygen/Nitrogen Species

Project Summary
Boron-Rich Cluster Materials for Vibrational- and Mass Spectral-Based Bioimaging of Reactive Oxygen/
Nitrogen Species
Reactive oxygen and nitrogen species (ROS/RNS) are redox signaling agents that underpin a myriad
of important biological processes but are also sources of oxidative stress and damage. Their
misregulation is implicated in neurodegenerative, autoimmune, and cardiovascular diseases. Activity-based
fluorescent sensors, which use chemical reactivity to track distinct ROS/RNS, are often deployed to
evaluate redox regulation in biology. However, the broad absorption and emission profiles inherent to
fluorescent readouts is a limitation when attempting to study multiple processes simultaneously via multiplex
bioimaging. Bioimaging approaches based on vibrational spectroscopy or mass spectrometry, such as
Raman and time-of-flight secondary ion mass spectrometry (ToF-SIMS), are emerging as attractive
alternatives to fluorescent imaging. The detection of narrow signatures inherent to vibrational readouts in
Raman, and the detection of ions in ToF-SIMS, surpasses the multiplexing capabilities of fluorescence
techniques. However, there do not exist activity-based sensors amenable to these imaging
approaches despite considerable progress in the availability of commercial instrumentation. Thus, the
long-term goal of this project is to develop boron-rich cluster imaging agents capable of monitoring an array
of distinct ROS/RNS via activity-based sensing (ABS) in a broad range of biological models across both
vibrational and ToF-SIMS bioimaging modalities. Boron-rich cluster compounds are underexplored in
the context of bioimaging. However, their unique electronic and physiologically benign properties can
enable them to serve as sensors for emergent imaging technologies. The B-H bonds on these cluster species
exhibit a stretching frequency that appears in a silent region in the vibrational spectra of biological samples.
Additionally, the efficient ionization of boron-rich clusters and distinct 11B isotope signature enables their
application in ToF-SIMS imaging. First, we will synthesize a panel of ROS/RNS responsive and cell
trappable boron-rich cluster sensors and evaluate their selectivity for distinct ROS/RNS. Second, we will apply
our sensors to monitor ROS/RNS localization in ToF-SIMS bioimaging experiments of mammalian cell models
of oxidative/nitrosative stress. In collaboration with RPL#1, we will translate our sensor platform to single
cell and tissue scale investigations of ROS/RNS involvement in chronic and neuropathic pain. The third aim
involves applying our developed sensors to obtain quantitative and spatial information on ROS/RNS fluxes
in Raman bioimaging experiments in mammalian cell models of oxidative/nitrosative stress. In collaboration
RPL#5, we will deploy our sensor platform to monitor and quantify ROS/RNS effects in vasculogenesis and
angiogenesis. Our boron cluster ABS imaging agents will complement both fundamental and translational
chemical biology research by enabling us to further elucidate ROS/RNS-mediated communication across a
broad range of clinically relevant biological models.

Public health relevance
PROJECT NARRATIVE Project Narrative is not required in this component